Leadership, Planning and Evaluation

PROJECT SUMMARY/ABSTRACT–Leadership, Planning and Evaluation
Planning and evaluation activities by leadership and a carefully assembled network of advisory committees are
critical to the success of the St. Jude Comprehensive Cancer Center (SJCCC). Through these efforts, including
the development and dynamic evaluation of a robust 8-goal SJCCC strategic plan, we provide support and
strategic direction to guide the work of our members in our shared mission of advancing research and cures for
pediatric cancer while reducing treatment-related morbidities. Planning and evaluation activities within the
SJCCC are led by the Director, Dr. Charles Roberts, and a Senior Leadership team of 7 Associate Directors
who work with him to refine and implement his overarching vision, define strategic research priorities and provide
high-level management of the Center's scientific, clinical, educational, and outreach endeavors. Senior
Leadership is supported by a Cancer Center Advisory Committee composed of the Director, Associate
Directors and Program Leaders. This committee provides an effective hub for collaboration, provides input on
the scientific direction of the research programs, assesses effectiveness of the Shared Resources and clinical
trial infrastructure, and identifies new resource needs to stimulate scientific collaboration among the Programs.
A highly engaged, expert External Advisory Board has annual visits to campus, augmented by interim
teleconferences when needed, and provides recommendations that are disseminated by the Director through
the internal committees for discussion, refinement, and implementation. All levels of leadership contribute to
strategic planning, an ongoing, dynamic process that has been significantly enhanced by working groups created
by Dr. Roberts. The efforts of our SJCCC leadership and advisory groups were highly impactful in the current
project period. Major achievements include the culmination of the year-long planning process resulting in a robust
8-goal SJCCC strategic plan, enabling the resultant launch of a new St. Jude-funded Clinical Research
Consortium and scientific Collaboratives in pressing research areas; recruitment of leading experts to drive
progress in strategic priority areas; and the development and launch of new precision medicine trials. These
groups also led the overhaul of SJCCC membership to support cancer-focused research goals and the
implementation of key operational changes to improve Shared Resources, leadership structure and infrastructure
in alignment with the SJCCC mission. By providing ongoing review and assessment of the goals of the Center,
our leadership and advisory committees ensure that strategic priorities are continuously pursued and refined to
respond to emerging needs. As well as continuing to execute on strategic plan goals, future plans include
expanding external research collaborations, soliciting and evaluating annual “Blue Sky” proposals from members
in innovative areas, and expanding strategic efforts in pediatric cancer education and outreach.